Next-generation technologies for autoantigen detection in sex-biased autoimmunity

Project Summary
Autoimmune diseases disproportionately affect women, who represent four out of five of ~50 million Americans
living with these diseases. In part, this is due to an RNA named Xist that is expressed in every cell in a woman’s
body, which performs important functions but also can drive autoimmunity associated with anti-Xist RNP
antibodies (AXA) against the proteins bound to Xist. However, the spatial expression patterns of the proteins
bound to Xist in the tissues affected by autoimmunity are still unknown, and population-level profiling for AXA in
women is currently a cost-prohibitive endeavor. We will use spatial proteomics to identify the spatial patterns of
expression of the Xist RNP complex in five human tissues targeted by XIST-driven autoimmunity: skin (affected
by SSc), kidney (affected by SLE), skeletal muscle (affected by DM), lung, and heart. We will also correlate the
patterns of AXA staining in HEp-2 male laryngeal carcinoma cells that are typically used for testing for
autoimmunity but may miss AXAs, as well as U-2 OS female osteosarcoma cells that express Xist and are used
for staining all human proteins in the Human Protein Atlas (HPA) subcellular atlas. This will enable us to apply
advanced computational models, such as self-supervised classification of protein localizations using vision
transformer models, as well as building multiscale integrated cell (MuSIC) models, to better interpret the biology
underlying AXA staining patterns. Finally, we will streamline antigen discovery in female-biased immunity by
leveraging the proteome-wide antigen and antibody resources of the Human Protein Atlas. With a new high-
throughput method to profile AXA for women, we can make a potentially transformative advance in women’s
health by better identifying Xist-biased autoimmunity and laying the groundwork to develop better treatments for
sex-biased autoimmunity.

Public health relevance
Project Narrative Autoimmune diseases disproportionately affect women, who represent four out of five of ~50 million Americans living with these diseases. In part, this is due to an RNA named Xist that is expressed in every cell in a woman’s body, which performs important functions but also can drive autoimmunity associated with anti-Xist RNP antibodies (AXA). We will leverage the resources of the Human Protein Atlas to discover the spatial patterns of Xist-bound protein expression in five human tissues affected by XIST-driven autoimmunity, and we will develop a new technology capable of population-level screening for AXA to better identify autoimmune diseases in women.